Impact of Anticholinergic Medication on Salivary Function; Exploring Potential Genetic Markers for Dry Mouth

The growing medication use in all ages led to the fact that 20% of the US adult population take five or more
drugs (polypharmacy). Over 500 medications commonly prescribed in polypharmacy (e.g., antidepressants,
urinary antispasmodics, and psycholeptics) possess anticholinergic (AC) properties blocking the muscarinic
signaling of neural regulation. Due to the scattered distribution of muscarinic receptors in the body, AC
medications have a wide range of side effects. Besides the most severe central toxicity of cognitive impairment,
dyskinesia, and psychosis, which can lead to delirium, the most frequent peripheral side effect is dry mouth. Dry
mouth is characterized by reduced saliva secretion (hyposalivation), impaired quality of life by causing chewing
or swallowing problems, complaints of oral dryness (xerostomia), speaking difficulties, mucosal changes,
increased rate of dental caries, and tooth loss. Dry mouth causes increased susceptibility to bacterial colonization
and infections in the oral cavity and the upper respiratory tract. However, no data are available on predicting
medication-induced dry mouth severity or determining the AC burden from these medications among dental
patients. There is a significant research gap in identifying high-risk xerostomia patients in the middle-aged
population before reaching older ages when damage to oral health is irreversible. We designed a prospective
cohort study with two aims for addressing these questions. In Aim 1., we will evaluate the correlation between
AC burden and dry mouth outcomes, including the flow rates of the minor salivary glands (SG) in 90 middle-
aged patients (45-64 years). We will determine whether high AC burden, quantified by the AC drug score (ADS)
and serum AC activity (SAA) in blood, is associated with more severe dry mouth symptoms, measured at
baseline and follow-ups for two years. We will assess dry mouth using saliva flow rates (unstimulated whole
saliva and minor SGs) and oral health measures associated with dry mouth, including xerostomia, dental caries,
and oral health impact profile. In this aim, we will examine the feasibility of minor SG flow screening as a point-
of-care test for dry mouth. In Aim 2., we will explore whether CYP450 genetic polymorphisms predict dry mouth
severity. Recent studies reported an increased prevalence of AC side effects in patients with inactive genetic
variants of liver cytochrome P450 enzymes responsible for the metabolic clearance of AC drugs. We will analyze
DNA from patients’ blood for the genetic variations of CYP2D6 and CYP2C19 enzymes and compare oral health
outcomes associated with dry mouth between poor and normo-metabolizing phenotypes. We propose to study
whether dry-mouth pharmacogenetics provides evidence for inter-individual variability in oral health outcomes to
identify patients with predictable severity of AC medication-induced dry mouth. The overarching goal of our
explorative study is to establish clinically relevant associations between AC burden and oral health outcomes,
which can support future investigations of potential causal relationships and risk calculations for dry mouth
development.

Public health relevance
Dry mouth is the frequent side effect of medications, which impairing the cholinergic stimulation of saliva secretion can lead to dry mouth, dental caries, soft tissue damage, and problems with speaking and swallowing. While the saliva secretion is very sensitive to these anticholinergic medications showing a significantly increased usage among adults, information on the oral health side effects is minimal. We propose to assess the salivary secretion and oral health outcomes in dental patients taking anticholinergic medications and explore the role of genetic variations of drug-metabolizing enzymes in the development of dry mouth.